Mitochondrial Dysfunction and Adipose Insulin Resistance

DESCRIPTION (provided by applicant): A variety of animal, cell culture and molecular studies have correlated increased oxidative stress and the accumulation of reactive oxygen species (ROS) such as superoxide anion and hydroxyl radicals to type 2 diabetes. While appreciated for years, it was unclear if oxidative stress / ROS was a casual or causal factor in the etiology of the disease. However, more recent work utilizing a variety of loss and gain of function analyses have indicated that oxidative stress is causally linked to insulin resistance but that the molecular mechanisms remain obscure. This application will profile new and compelling findings from our laboratories using animal and cell culture models that establish a molecular linkage between the antioxidant defense system in adipose cells with mitochondrial function, oxidative phosphorylation, signal transduction and the development of insulin resistance. We present a novel hypothesis supported by preliminary studies from genomic, proteomic, metabolomic and molecular analyses that point toward the covalent modification of mitochondrial proteins with bioactive lipids and the oxidation of mitochondrial thioredoxin as central to the process. Initiating this oxidative stress challenge are new findings that describe the tumor necrosis factor 1 (TNF1) dependent down regulation of glutathione S-transferase A4 setting the stage for a molecular cascade of events that activates the c-JUN NH2-terminal kinase (JNK), an established regulator of insulin sensitivity. Moreover, we present new findings that demonstrate that the down regulation of GSTA4 is not merely a process observed in animal models of insulin resistance but also occurs selectively in obese, insulin resistant, but not obese, insulin sensitive humans thereby providing a molecular differentiation between obesity and insulin resistance. This application builds on recent evidence obtained in the Bernlohr, Griffin and Arriaga laboratories that functionally links oxidative stress to insulin resistance. These studies in sum lead to our central hypothesis: decreased expression of GSTA4 in adipocytes leads to increased carbonylation of multiple protein targets. Carbonylation in turn initiates a cascade of molecular events leading to mitochondrial dysfunction and ROS production. ROS production leads to the oxidation of Thioredoxin 2 (Trx2) and the activation of Trx2-ASK1-JNK/p38 signaling system contributing to insulin resistance. To test this hypothesis, the following four specific aims are proposed: Specific Aim 1. Evaluate mitochondrial protein carbonylation and identify target proteins. Specific Aim 2. Assess ROS production and mitochondrial electron transport system in cell culture and animal models. Specific Aim 3. Develop and characterize aP2-HA-GSTA4 transgenic mice maintained on low and high fat diets. Specific Aim 4. Characterize cellular metabolism and the Trx2-ASK1-JNK pathway in animal and cell culture models.

Public health relevance
PUBLIC HEALTH RELEVANCE: A variety of animal, cell culture and molecular studies have correlated increased oxidative stress and the accumulation of reactive oxygen species (ROS) to type 2 diabetes. While appreciated for years, it was unclear if oxidative stress / ROS was a casual or causal factor in the etiology of the disease. This application will profile new and compelling findings from our laboratories using animal and cell culture models that establish a molecular linkage between the antioxidant defense system in adipose cells with mitochondrial function, oxidative phosphorylation, signal transduction and the development of insulin resistance. We present new findings that demonstrate that the down regulation of GSTA4 is not merely a process observed in animal models of insulin resistance but also occurs selectively in obese, insulin resistant, but not obese, insulin sensitive humans thereby providing a molecular differentiation between obesity and insulin resistance. If the hypothesis is proven to be correct, the study would be immediately translatable to human biology and afford a new view of how type 2 diabetes may be combated. 7. PROJECT NARRATIVE A variety of animal, cell culture and molecular studies have correlated increased oxidative stress and the accumulation of reactive oxygen species (ROS) to type 2 diabetes. While appreciated for years, it was unclear if oxidative stress / ROS was a casual or causal factor in the etiology of the disease. This application will profile new and compelling findings from our laboratories using animal and cell culture models that establish a molecular linkage between the antioxidant defense system in adipose cells with mitochondrial function, oxidative phosphorylation, signal transduction and the development of insulin resistance. We present new findings that demonstrate that the down regulation of GSTA4 is not merely a process observed in animal models of insulin resistance but also occurs selectively in obese, insulin resistant, but not obese, insulin sensitive humans thereby providing a molecular differentiation between obesity and insulin resistance. If the hypothesis is proven to be correct, the study would be immediately translatable to human biology and afford a new view of how type 2 diabetes may be combated. __SpecificAimsTextDelimiter__ Mitochondrial Dysfunction and Adipose Insulin Resistance 2. SPECIFIC AIMS The molecular and mechanistic linkage between obesity and metabolic disease such as type 2 diabetes, hypertension and cardiovascular disease is complex and likely brought about by a combination on hormonal, metabolic and genetic determinants (Hsu et al., 2007; Misra and Khurana, 2008; Oda, 2008; Schenk et al., 2008; Wang et al., 2008). Not all obese individuals develop metabolic diseases and not all individuals that develop metabolic disease are obese (James, 2008; Petersen and Shulman, 2006; Votruba and Jensen, 2007). As such, while obesity is a positive risk factor for such conditions, the mechanisms that link such processes are multi-factorial and our understanding of the molecular mechanisms that lead to such conditions will in all likelihood need a systems biology approach involving genomic, proteomic and metabolomic technologies. This application links long-standing studies in the Bernlohr laboratory on adipose biology and obesity-linked type 2 diabetes, the Griffin laboratory on quantitative proteomics, and the Arriaga laboratory on oxidative phosphorylation and mitochondrial metabolism. The combined expertise of the three University of Minnesota labs in genomic, proteomic, and animal/cell culture models of disease represents a unique confluence of technologies and insights. Each laboratory studies oxidative stress and the role(s) of reactive oxygen species in disease and have joined forces in this application for novel studies on the molecular determinants linking obesity to insulin resistance. A variety of animal, cell culture and molecular studies have correlated increased oxidative stress and the accumulation of reactive oxygen species (ROS) such as superoxide anion and hydrogen peroxide to type 2 diabetes (Anderson et al., 2009; Anedda et al., 2008; Choi et al., 2008; Grimsrud et al., 2008; Houstis et al., 2006). While appreciated for years, it was unclear if oxidative stress / ROS was a casual or causal factor in the etiology of the disease. However, more recent work utilizing a variety of loss and gain of function analyses have indicated that oxidative stress is causally linked to insulin resistance but that the molecular mechanisms remain obscure ((Anedda et al., 2008; Song et al., 2008)). This application will profile new and compelling findings from our laboratories using animal and cell culture models that establish a molecular linkage between the antioxidant defense system in adipose cells with mitochondrial function, dysfunctional oxidative phosphorylation, signal transduction and the development of insulin resistance. We present a novel hypothesis supported by preliminary studies that point toward the covalent modification of mitochondrial proteins and the oxidation of mitochondrial thioredoxin as central to the process. We report new findings that describe one specific antioxidant enzyme, glutathione S-transferase A4 as being transcriptionally regulated by tumor necrosis factor α (TNFα) and the reduced expression of GSTA4 setting the stage for a molecular cascade of events that activates the c-JUN NH2-terminal kinase (JNK), an established regulator of insulin sensitivity (Kaneto et al., 2005; Valerio et al., 2006; Vallerie et al., 2008). Moreover, the down regulation of GSTA4 is not merely a process observed in animal models of insulin resistance but also occurs selectively in obese, insulin resistant, but not obese, insulin sensitive humans thereby providing a molecular differentiation between obesity and insulin resistance. This application builds on recent evidence obtained in the Bernlohr, Griffin and Arriaga laboratories that functionally links oxidative stress to insulin resistance. These studies in sum lead to our central hypothesis: decreased expression of GSTA4 in adipocytes leads to increased carbonylation of multiple protein targets. Carbonylation in turn initiates a cascade of molecular events leading to mitochondrial dysfunction and ROS production. ROS production leads to the oxidation of Thioredoxin 2 (Trx2) and the activation of Trx2-ASK1-JNK/p38 signaling system contributing to insulin resistance. To test this hypothesis, the following four specific aims are proposed: Specific Aim 1. Evaluate mitochondrial protein carbonylation and identify target proteins. Specific Aim 2. Assess ROS production and mitochondrial electron transport system in cell culture and animal models. Specific Aim 3. Develop and characterize aP2-HA-GSTA4 transgenic mice maintained on low and high fat diets. Specific Aim 4. Characterize cellular metabolism and the Trx2-ASK1-JNK pathway in animal and cell culture models.